Modern Equipment for Shared-use Biomedical Research Facilities: Advancing Research-Related Operations (S15 Clinical Trial Not Allowed)

Project Summary/Abstract:
The AAALAC, International accredited, University of Rochester requests this Equipment Grant
funding to purchase a bulk, Gruenberg™ Dry Heat Sterilizer to double sterile mouse cage throughput
to meet growing program needs as well as to reduce labor and utilities expenses. All mouse caging
is sterilized before each use. Ultrafiltered (0.1 micron), municipal water is provided by the
Hydropac™ system. Two separate, vivaria, Kornberg Medical Research Building KMRB (23,273 sq ft)
and School of Medicine & Dentistry SMD (53,861 sq ft) each house approximately 9,000 autoclaved
cages of SPF mice on HEPA-filtered, ventilated racks. The KMRB, built in 1999, modernized and
doubled the University's mouse-based, research capacity by designing efficient use of suites
adjacent to a modern cagewash and housing mice in seventy-five, labor-saving, HEPA-filtered,
ventilated racks. The high throughput bulk, steam autoclave and tunnel washer in the KMRB met
the needs of the new SPF mouse facility with intentional excess capacity for expansion into
adjacent shell space. The SMD vivarium, built in 1965, originally met the needs of over 300
conventionally housed dogs, 150 macaques, 60 cats, 200 rabbits and 1 0 rooms of conventional
rodents housed on 7 floors in the SMD. The original SMD cagewash design included three passthrough
cage/rack washers in the wall between two equally sized, soiled and clean sides. Over
time, the SMD large animal census has declined to less than 30 macaques, 7 rabbits and no dogs or
cats. In contrast, the SPF mouse census in the SMD has increased to over 9,000 cages all housed
in HEPA-filtered, ventilated racks. The SMD Vivarium supports 98 principal investigators across 38
departments. A total of $277M funded mouse-based research ($184M NIH, $33M Institutional,
$23M Corporation, $15M Foundation, $1 OM DOD, $12M Other) depends on the outdated SMD
vivarium cage wash. SMD cage wash facility currently includes one cage/rack washer and two,
small chamber autoclaves. In January 2024, we achieved a first step to modernize the SMD cage
wash facility for mice by replacing one of the two rack washers with a Vivus Technologies™ tunnel
washer. While the new tunnel washer has significantly advanced more efficient mouse cage
washing, the cabinet autoclaves continue to pose a bottle neck with low through-put. If awarded
this $350,000 equipment grant, the university has committed an additional $57,000 for the
purchase of the $407,000 Gruenberg™ Dry Heat Sterilizer (Model VST40H280.OSS-2D-RM-G) plus
an additional $207,000 to prepare a level, heat resistant floor and bring the necessary electrical,
exhaust and compressed air utilities to the installation site. Addition of the Gruenberg™ Dry Heat
Sterilizer will reduce labor and utilities expenses for SM D's current 10,000 cage census as well as
position the university for meeting the needs of new recruits even with a doubling of the mouse
cage census.

Public health relevance
Project Narrative: Biomedical research at the University of Rochester has advanced many medical miracles from heart implants for children to a vaccine that prevents cervical cancer. These breakthroughs were made possible using well cared for and healthy laboratory animals in a biosecure environment. The Gruenberg Dry Heat Sterilizer requested in this grant will improve the University’s ability provide the best housing for laboratory animals enrolled in our life-changing research.